Generating Robust anti-HIV CD8 T cells using HIV-targeted Liposomal Vaccines

Generating Robust anti-HIV CD8 T cells using HIV-targeted Liposomal Vaccines
Project Summary: HIV remains a major public health issue in the US, with thousands of new infections every
year. While advancements in anti-retroviral therapies (ART) have increased patient lifespans, ART does not
cure HIV infection, leaving patients reliant upon ARTs. HIV vaccines have had little success, owing to the
immune evasion, high mutability, and latent viral depots of HIV. Here, we propose a new strategy for
therapeutic HIV vaccines, the Nanotrap Therapeutic Vaccine (NTV). NTVs are modified liposomes consisting
of HIV targeting molecules that bind gp120 and/or gp41 and adjuvants that skew innate immune responses
toward Th1 and CD8+ T cell responses. NTVs are designed to be injected after HIV infection, but concurrent
with ART therapy when circulating viral loads are high. NTV will bind circulating HIV and be phagocytosed by
local APCs, thereby co-delivering both HIV viral particle and adjuvant to APCs, activating them. The activated
HIV+ innate immune cell will traffic to the lymph node and stimulate HIV specific CD8+ T cells, which can
eradicate latent viruses.
This proposal has two aims. First, we will optimize the HIV binding moiety of NTVs. By selecting from a library
of known gp120 and gp41 targeting molecules, typically used to inhibit HIV viral entry, we can synthesize lipid
formulations, incorporate them into liposomes, optimize their formulation and verify that these bind HIV and
inactivate the virus from infecting other cells. Second, after screening potential Th1 skewing adjuvants, we will
formulate adjuvant loaded NTVs and verify that these are taken up by local innate immune cells and can
generate anti-HIV CD8+ T cell responses both in vitro and in vivo. This project is innovative because 1) NTVs
selectively generate effector T cell responses, which have been shown to eliminate latent viral depots and 2)
NTVs can generate immune responses specific to the circulating virus in each patient, overcoming HIV’s high
mutability evasion strategy. If successful, this proposal would generate a new class of HIV vaccine and
potentially be the first step to curing HIV.

Public health relevance
Project Narrative: In contrast to most HIV vaccine efforts that seek strong antibody responses, most elite controllers of HIV have strong CD8+ T cell responses; however current vaccine therapies are unable to elicit strong anti-HIV effector T cells. Here we propose the engineering of modified liposomes, the Nanotrap Therapeutic Vaccine (NTV), which contain HIV binding molecules on its surface and adjuvants that skew immune responses toward CD8+ T cells loaded in the core. Circulating HIV can be trapped in vivo by NTVs and facilitate endogenous generation of anti-HIV CD8+ T cells that are patient specific to the HIV sub-strain.